Conditional knock-in of Gnb3/Gngt2 in mouse rod photoreceptors

ABSTRACT.
The G-protein Gb3 subunit encoded by the gene GNB3, is the protein present in multiple tissues
and cell types, including retinal cone photoreceptors, as part of the Gabg heterotrimers
responsible for the intracellular signaling initiated by the G-protein-coupled receptors, GPCRs.
There is evidence that mutations in GNB3 are associated with cardiovascular disease, metabolic
syndrome, obesity and visual impairment. Rare GNB3 mutations have been found associated
with retinal degeneration and congenital stationary night blindness. The mechanisms of these
pathophysiological conditions linked to GNB3 are poorly understood. In the retina, there is little
understanding of why members of the same gene family GNB3 and GNB1 are expressed
selectively in cone and rod photoreceptors, and what roles Gb3 and Gb1, in tight complexes with
the corresponding Gg subunit, Ggc and Gg1, contribute to the distinct properties of cone and rod
phototransduction and retinal diseases.
This pilot proposal focuses on the initial characterization of a unique mouse model that our
laboratory has developed to replace the entire rod Gb1g1 subunit complex with its cone analogue
Gb3gc. The proposal aims to collect critical preliminary data for a more comprehensive project
focusing on the specificity of retinal signaling and mechanisms of retinal disorders involving Gnb3.
This project builds the necessary foundation for further mechanistic studies of specific human
mutations, as well as the development of new therapeutic approaches.

Public health relevance
NARRATIVE Mutations in the gene GNB3 affect the function of the G-protein Gbeta3 subunit and lead to a variety of cardiovascular, metabolic and retinal disorders that currently have no cure. Our proposed research will determine the contribution of cone transducin Gbeta3 protein in retinal signaling and pathophysiology to establish foundation for further understanding of the disease mechanisms.